Development of Nanoneedle Array for Painless and Long-Term Sustained Intraocular Drug Delivery

PROJECT SUMMARY/ABSTRACT
Corneal neovascularization (CNV), or the invasion of new blood vessels into the avascular cornea, remains
one of the major causes of blindness worldwide. Topical eye drop therapy serves as the most easily accessible
and noninvasive treatment of CNV, but its therapeutic efficacy is limited due to the corneal barriers and
nasolacrimal drainage that quickly eliminates eye drops within a few minutes. Recent advances of biodegradable
microneedles have led to the development of many strategies for intraocular drug delivery through the corneal
barriers, which increases therapeutic efficacy. However, the clinical implementation of these microneedles in
human eyes is often impeded due to their relatively large size for the human cornea and rapidly dissolving nature
(typically, within 15 minutes-2 hours), which causes pain and limited therapeutic efficacy, respectively. The
research endeavors of this project will focus on the development of a new class of intraocular drug delivery
platform made from fully-miniaturized (i.e., at nanoscale) and slowly-biodegradable silicon nanoneedles that are
> 30-fold smaller and provide > 10-fold slower degradation rate compared to current biodegradable
microneedles. The silicon nanoneedles will be built upon a water-soluble contact lens that offers excellent
biocompatibility, softness, rapid degradability in tear fluid (within no more than 30 seconds), and optimal
curvature to fit a variety of corneal shapes (8.3-9.0 mm base curve radii). These aspects are essential to allow
for the minimally-invasive, painless, and long-term (over days) sustained delivery of ocular drugs through the
corneal barriers. In this project, we will reveal the structure-property-performance relationship of the silicon
nanoneedles with various size, shape, aspect ratio, and surface porosity in vitro and ex vivo. We will also
evaluate the biosafety, therapeutic efficacy, and side-effects of the silicon nanoneedles in a well-established
rabbit CNV model in vivo, as compared to conventional anti-vascular endothelial growth factor therapy (anti-
VEGF) and laser therapy. Because the materials used for both the nanoneedles and water-soluble contact lens
are already in clinical use, this intraocular drug delivery platform can be rapidly translated into clinical practice
for the treatment of CNV in human eyes. Furthermore, the established intraocular drug delivery platform will be
also useful for the treatment of other chronic ocular diseases, including corneal, retinal, and choroidal
neovascularization.

Public health relevance
PROJECT NARRATIVE Ocular drug delivery is challenging due to the complex structure of the cornea that impedes adequate drug delivery and therapeutic efficacy. This project aims to develop a minimally-invasive, painless, and effective ocular drug delivery platform through the innovation of fully-miniaturized and slowly-biodegradable (over days) silicon nanoneedles built upon a rapidly-dissolvable (within 30 seconds) water-soluble contact lens. This platform can yield a more controllable and longer-lasting drug release profile in a less-invasive manner compared to current gold-standard biodegradable microneedles, thus improving therapeutic efficacy.